Biological function and regulation of PRMT9 in synapse development

Project Summary
The goal of this project is to determine the molecular mechanisms by which pre-mRNA splicing is regulated by
protein arginine methylation, one of the most abundant post-translational modifications on the RNA binding
proteins, and to define the impact of this regulation in synapse development and brain function. The human
genome encodes nine protein arginine methyltransferases (PRMT1–9), which catalyze three types of arginine
methylation: monomethylation (MMA), asymmetric dimethylation (ADMA), and symmetric dimethylation (SDMA).
A few years ago, we characterized the newest member of the PRMT family–PRMT9 and identified the splicing
factor SF3B2 as the primary substrate of PRMT9, linking its function to pre-mRNA splicing. However, the
biological function of PRMT9 and the molecular mechanism by which PRMT9-catalyzed SF3B2 arginine
methylation regulates pre-mRNA splicing are still unknown. Recently, mutation of PRMT9 was identified in
autosomal recessive intellectual disability (ID) from a large whole genome sequencing study of 136
consanguineous families, underscoring the significance of understanding the biological function and regulation
of this newest PRMT. In our preliminary studies, we determined that the ID-associated PRMT9 mutation
abolishes its arginine methyltransferase activity on SF3B2, and the mutant protein is unstable and subject to
heavy ubiquitination. By establishing a novel Prmt9 conditional knockout mouse model, we revealed that PRMT9
loss causes abnormal synapse development and impairs mouse learning and memory. Mechanistically, we
discovered a critical protein-RNA interaction between the arginine 508 (R508) of SF3B2, the site that is
exclusively methylated by PRMT9, and the pre-mRNA anchoring site, a cis-regulatory element located upstream
of the branch point sequence (BPS). Additionally, we uncovered two molecular pathways that regulate PRMT9
expression at the mRNA and protein levels. Built upon these exciting discoveries, our central hypothesis is that
PRMT9-mediated arginine methylation regulates SF3B2–anchoring site interaction and U2 snRNP recruitment,
a process that is critical for pre-mRNA splicing and brain development. This hypothesis will be tested in three
specific aims: 1) determine how PRMT9-mediated SF3B2 arginine methylation regulates pre-mRNA splicing; 2)
define the molecular pathways that regulate PRMT9 expression; and 3) investigate how PRMT9 loss-of-function
impacts synapse development and circuit connectivity. Successful completion of these proposed studies will
reveal a novel and fundamental molecular network underlying the regulation of RNA splicing in brain
development. The key pathways revealed in this study could be harnessed as targets for treating
neurodevelopmental disorders.

Public health relevance
Project Narrative The proposed research will reveal novel mechanisms underlying the regulation of pre-mRNA splicing in brain development. It will have significant impacts on the field of RNA biology and neurodevelopment. Because pre- mRNA splicing is a fundamental cellular process that is often mis-regulated in human diseases, the molecular mechanisms revealed in this study will have broad implications for translational medicine.